Genomic reprogramming in the early embryo

PROJECT SUMMARY
Our long-term goal is to elucidate the molecular mechanisms that restructure the genome to allow for
developmental transitions. This process is orchestrated by sequence-specific, DNA-binding, transcription
factors that occupy discrete regulatory regions and drive gene expression. However, the packaging of the
genome into chromatin limits the ability of many transcription factors to bind the underlying DNA. A specialized
class of transcription factors, called pioneer factors, are uniquely capable of binding histone-wrapped DNA,
establishing accessible chromatin domains, and facilitating the binding of additional transcription factors. These
distinctive properties enable pioneer factors to act at the top of gene-regulatory networks to drive changes in
cell state. Indeed, pioneer factors are required for reprogramming the early embryonic genome in all species
studied. We identified two pioneer factors in Drosophila, Zelda and GAGA factor, that are each essential for
embryonic development and together partition the embryonic genome into transcriptionally active and inactive
states. Nonetheless, the mechanisms by which these two factors function to drive this conserved
developmental transition remains unclear. Despite the powerful ability of pioneer factors to restructure the
genome, there are barriers to both their binding and activity. By combining our development of novel tools to
interrogate transcription-factor function in the early embryo with the strengths of the well-studied fly system, we
are uniquely positioned to determine essential features of pioneer-factor mediated genomic reprogramming.
We will use genetic, genomic, biochemical, and imaging strategies to determine how pioneer factors partition
the early embryonic genome into the transcriptionally active and inactive compartments and identify pioneer-
specific features that promote their ability to restructure the genome. Our proposed research is significant
because we will identify unifying principles by which pioneer factors drive the changes in gene-regulatory
networks that promote developmental transitions and, when dysregulated, disease.

Public health relevance
PROJECT NARRATIVE Pioneer transcription factors are uniquely capable of binding closed chromatin and promoting chromatin accessibility to drive developmental transitions. Because of their powerful ability to reprogram the gene- expression network, misexpression of pioneer factors are also associated with profound cellular disfunction. By studying conserved developmental transitions, we will define the fundamental mechanisms that endow pioneer factors with their ability to restructure the genome and in so doing provide insights into both normal development and disease states.